Molecular mechanisms of somatosensory adaptation to prolonged hypothermia

Project Summary/Abstract
Mechanosensitivity and mechanotransduction are fundamental processes that affect virtually all aspects of
human physiology. Sensitivity to mechanical stimuli ranges from light touch to unpleasant or painful and relies
on the ability of primary sensory afferents to transduce these stimuli into electrical signaling. In humans,
dysfunctions of the somatosensory system have only symptomatic or palliative care, largely because the
molecular and cellular aspects of mechanosensitivity and mechanotransduction, and the sequence of events
that underlies somatosensory tuning remain enigmatic. Our long-term goal is to understand general principles
somatosensory mechanotransduction under normal, adaptive, and pathological conditions.
In this collaborative basic scientific proposal, we seek to uncover the mechanism underlying adaptations of
mammalian mechanosensory system to cold. We will approach this problem using a novel model organism—
hibernating thirteen-lined ground squirrel (Ictidomys tridecemlineatus). Despite the prolonged severe
hypothermia during hibernation, when body temperature drops to less than 10°C, squirrels maintain the ability
to detect mechanical force and can be aroused by touch and vibration. The endurance of the sense of touch
despite prolonged hypothermia supports the existence of specific molecular and cellular adaptations at the level
of peripheral mechanoreceptors. We seek to uncover these adaptations by biophysical analysis of ion channels
in peripheral mechanoreceptors that determine baseline excitability, convert touch into excitation and generate
and propagate action potential, implementing a mechanosensory tune-up that preserve touch sensitivity despite
prolonged exposure to cold. This proposal will elucidate tunable molecular pathways in mammalian
mechanosensory neurons to inform clinical practices mitigating somatosensory dysfunctions following
hypothermia or nerve damage.

Public health relevance
Project Narrative Molecular and cellular mechanisms that contribute to the modulation of mechanotransduction and mechanosensitivity under normal, pathological, or adaptive conditions remain to be fully elucidated. The objective of this proposal is to investigate biophysical basis of mechanosensitivity under conditions of prolonged hypothermia, using hibernating thirteen-lined ground squirrels as a naturalistic model. Insights gleaned from these studies will facilitate rational development of pharmacology to alleviate symptoms associated with neuropathic somatosensory dysfunction in humans.